Structural Studies of Beta-2 glycoprotein I in the Antiphospholipid Syndrome

Project Summary/Abstract
Beta-2 glycoprotein-I (b2GPI) is a 50-kDa glycoprotein that circulates in the blood at a concentration of 0.2
mg/ml. It was originally discovered in 1961 but received little attention until 1990 when it was identified as the
dominant antigen of antiphospholipid antibodies (aPL) in the autoimmune disorder known as
Antiphospholipid Syndrome (APS). Patients affected by APS develop blood clots in veins and arteries as well
as pregnancy complications. Occlusions of the vascular system may lead to life-threatening complications such
as myocardial infarction, pulmonary embolism and stroke. Despite the established correlation between the
presence of anti-b2GPI antibodies and thrombosis, APS remains incredibly challenging to diagnose and
treat for physicians. There are two main issues. First, anti-b2GPI antibodies are very heterogeneous, and not
all of them are pathogenic. Hence, laboratory tests are difficult to develop, standardize and interpret. This affects
our ability to identify, with confidence, patients at higher risk for thrombosis who require prompt pharmacological
intervention. Second, treatment options are limited to the prophylactic administration of long-term anticoagulants,
anti-platelets, and low molecular weight heparin, that block the downstream effect of aPL, i.e., activation of the
clotting cascade. This mechanism of action, however, is non-optimal for treating APS patients and, in addition to
negatively affecting patients’ lifestyle and exposing them to the risk of fatal bleeding, among other things, these
drugs also fail to prevent thrombotic recurrences in ~30% of the APS patient population, especially in those
individuals with arterial thrombosis. To address these unmet clinical needs, physician and basic scientists have
joined forces over the past twenty years and launched several key initiatives with the goal of standardizing the
diagnosis of APS patients and determining the optimal management of aPL-positive patients. Thus,
understanding the role of b2GPI in APS became a top priority in the field. Thanks to these collective efforts,
much has been learned about the subclasses of aPL causing thrombosis and the signaling pathways triggered
by anti-β2GPI antibodies. Less clear, however, remain the structural properties of β2GPI, the mechanisms
controlling antigen-antibody recognition and the circumstances under which β2GPI becomes immunogenic. To
bridge this gap in our fundamental knowledge, this research project seeks to elucidate the structural
architecture β2GPI under conditions relevant to physiology, define the structural determinants for the
interaction of β2GPI with aPL and physiological ligands, and develop an improved diagnostic test for the
detection of pathogenic anti-b2GPI antibodies in patients’ plasma. Information gathered through these
studies will contribute to establishing the missing link between structure, function, and immunogenicity of β2GPI
in APS, and will open new avenues for APS-specific diagnostics and therapeutics.

Public health relevance
Project narrative In the autoimmune disorder called Antiphospholipid Syndrome (APS), the presence of autoantibodies targeting the plasma glycoprotein beta-2 glycoprotein I (b2GPI) is associated with arterial and venous thrombosis as well as pregnancy complications. Understanding how b2GPI becomes immunogenic and how autoantibodies in complex with b2GPI cause the blood to clot remains a top priority in the field. By elucidating the structural architecture of b2GPI free and bound to physiological and pathological ligands, our studies have the potential to shed new light on the pathogenic mechanisms of APS and will enable the development of new diagnostics and therapeutic approaches.